Students and Teachers Achieving Cancer Research Experiences Together (START) Program

The community immediately surrounding the University of Colorado Anschutz Medical Campus (AMC) and the
University of Colorado Cancer Center (UCCC) includes underserved secondary schools with a large percentage
of students from populations underrepresented in science and research. We aim to expand representation of
local students in science careers through an innovative program that fills gaps in cancer research and science
education in local schools. Our Students and Teachers Achieving Cancer Research Experiences Together
(START) program will inspire 7-12th grade students from underrepresented groups (URs) and their families to
see cancer research as an exciting and attainable profession. START will also provide 7-12th grade teachers
with research and training experiences to facilitate delivery of novel cancer science curricula in community
classrooms. The START program vision is to transform our community by enabling students from URs to
envision themselves as the next generation of scientific leaders and pursue advanced biomedical careers while
also increasing the local community’s understanding of cancer research and prevention. We will achieve this
vision with three aims: Aim 1: Engage secondary students in cancer biology science experiences that expose
them to new career pathways while building their engagement and identity in science and research, Aim 2:
Transform local science education by engaging science teachers in mentored cancer biology research
experiences, providing high quality professional development, and supporting development and delivery of
biomedical science curricula, Aim 3: Provide community engagement and outreach opportunities for the
neighboring community to learn about cancer research, cancer prevention, and cancer disparities through
interactions with AMC scientists. All three aims include curriculum development and implementation
components. Outcomes and products of the START program will include novel cancer research curricula,
cancer-focused summer camps, college credit for research students, a bioscience lending library for teachers, a
teacher network for sharing cancer research teaching ideas and best practices, a teacher certificate with 18
graduate credits, increased interest in research education and careers from local students and families, and
community engagement by UCCC centered around cancer research and prevention. To foster students’
continued interest in cancer research, we will provide college preparation sessions and assist START alumni
with applying to undergraduate research programs at UCCC. We have a strong pool of scientists to mentor and
teach in START, including underrepresented faculty, students, and postdoctoral fellows. START will engage
diverse cohorts of 7-12th grade students, teachers, and community members to share in hands-on cancer
research and education designed to cultivate ongoing participant success. The proposed aims will address our
overall goals by stimulating increased interest in research, generating community and AMC support for local
students pursuing research careers, and building the earliest steps in a pathway to biomedical research careers
at UCCC.

Public health relevance
Project Narrative Opportunities to engage in hands-on science and research experiences in middle and high school spark curiosity and stimulate interest in research as a career path. The START program will transform our community by cultivating and strengthening research skills and inspiring historically underrepresented students to envision cancer research as a profession. The proposed aims will provide mentored cancer research experiences for secondary school students and teachers, facilitate college credits for students and teachers, deliver summer science camps focused on cancer research, offer community outreach events with cancer research and prevention themes, develop new biomedical science outreach and classroom curricula, and supply teachers with resources and mentoring to implement biomedical science activities in their classrooms.